Immune Modulation During Acute Lyme Disease Infection as the Result of Aberrant Immunoglobulin Glycosylation

Abstract: Lyme disease (LD) leads to lifelong health problems if standard antibiotic therapy is not initiated
during the first 2-3 weeks after infection. Diagnosis for LD currently relies on seroconversion and is unreliable
during acute disease. Cases of suspected acute LD should be confirmed using clinical diagnostic assays. N-
linked glycosylation is one of the most abundant post-translational modifications of serum proteins. While it is
dynamic in nature, it is also highly consistent in a healthy state. N-linked glycosylation of serum immunoglobulins
(Igs) are known to change in a disease specific manner and can direct the host immune response toward a pro-
or an anti-inflammatory response. We previously observed that Ig N-glycans produced during acute LD contain
specific alterations in the abidance of galactose and sialic acid. We hypothesize that these Ig alterations are
antigen-specific, and that the glycosylation patterns present will negatively impact downstream immune
responses. This hypothesis is based on our preliminary data, known LD B-cell perturbations, and reports of IgG
N-glycans altering the immune response to COVID-19, tuberculosis, multiple sclerosis, and HIV.
This proposal is novel and unique because it is the only study that examines the role of glycosylation
during the human immune response to LD. This proposal is built on our preliminary work where we identified
aberrant glycosylation on the total serum IgG and IgM in acute LD patients prior to seroconversion. In this
proposal, we examine the glycosylation of Igs specific to LD antigens and determine if acute LD infection will
alter B-cell responses to produce antigen specific Igs with the same unique glycosylation changes seen in our
preliminary data. Additionally, we examine how the glycosylation pattern on antigen specific Igs effect the
immune response to LD.
In Aim 1, we isolate Igs specific to the LD antigen VlsE and establish the IgG and IgM N-glycan profiles.
The result will determine if antigen specific Igs contain the same aberrant glycosylation found in the total Ig
population of acute LD patients. In Aim 2, we quantify the impact of LD antigen-specific IgG glycosylation on the
promotion of ADCC and complement deposition. The result will determine if there is a link between IgG
glycosylation and the inability of the patients to clear the Borrelia burgdorferi spirochete that causes LD. In Aim
3, we quantify the impact of antigen-specific IgM glycosylation on the complement deposition rate. Complement
deposition leads to rapid clearance of Lyme disease pathogens. Altered glycosylation of IgM could impair
complement deposition and impede the ability of the human host to clear the infection.
This work will establish a new mechanism of Borrelial immune evasion, characterize the host-response
to LD pathogenesis in humans. Additionally, the results will potentiate the use of Ig N-glycans to serve as
multiplexed biomarkers in a novel Lyme disease diagnostic assay and guide the glycoengineering of
antibodies for use in intravenous therapy in hard-to-treat disseminated Lyme disease cases.

Public health relevance
Narrative Approximately 500,000 Americans contract Lyme disease and urgently require antibiotic therapy early in their infection to prevent irreversible damage to their joints, heart, and brain. The proposed research seeks to understand the basis of a patient’s inability to clear the bacterial infection and develop a sustained immune response that can provide protection from future reinfections. These results will also inform the development of potential biomarkers to improve diagnostic testing and glycoengineering of intravenous antibody therapy.